Evaluation Methods and Intervention Strategies Core

Project Summary/Abstract – Evaluation Methods & Intervention Strategies Core
The Evaluation Methods and Intervention Strategies Core (EMIS) Core’s mission is to assist investigators in
the study design, protocol development, data acquisition/collection, statistical analysis, implementation and
dissemination to examine questions related to the causes, prevention, and effective management of diabetes,
its complications, and comorbidities. The EMIS Core supports investigators through consultation and
collaboration, leads work-in progress sessions, develops and maintains centralized resources, and conducts
workshops. In order to create economies of scale and leverage other resources, the EMIS Core’s activities are
coordinated with other UM Centers and Institutes to provide a comprehensive, multidisciplinary approach to
support translational research.
The Specific Aims of Evaluation Methods & Intervention Strategies Core are:
1. To consult with investigators regarding study design, protocol development, data acquisition/collection,
statistical analysis, implementation and dissemination of behavioral, clinical, health equity, and health systems-
related translational research studies focused on the causes, prevention and management of diabetes, its
complications, and comorbidities.
2. To conduct advanced biostatistical analyses, simulations, cost analyses, and data management in
collaboration with funded investigators.
3. To facilitate the use of the Michigan Model of Diabetes Progression (MMDP) to evaluate the cost and health
utilities of interventions and to rigorously assess cost-effectiveness.
4. To provide support for studies seeking to improve accessibility and effectiveness of care support using
mobile, telephone, or web-based tools in populations experiencing health disparities.
5. To support communication, collaboration and central resources for investigators working on translational
research.
The Core includes personnel with skills in using mobile, telephone, or web-based tools and in epidemiological
methods; survey methodology; psychometric measurement; quasi-experimental designs; quality measurement
and practice profiling; Managing, merging, and analyzing large administrative and clinical databases; and
advanced biostatistical analysis and economic modeling.